Elucidating molecular mechanisms of psychological well-being

We propose to investigate molecular mechanisms that underlie individual differences in psychological
well-being (PWB). PWB is a multidimensional construct that encompasses positive emotion, life satisfaction,
and sense of purpose and meaning in life, and is more than the absence of negative emotional states. Many
prospective longitudinal studies have shown that PWB is associated with better mental and physical health
after adjusting for negative emotion and other relevant confounding factors. Indeed, PWB mitigates risks of
having suicide ideation, depression, substance abuse, post-traumatic stress disorder, Alzheimer's dementia,
heart disease, diabetes, and reduces all-cause mortality.
Notably, PWB has a substantial genetic contribution with a heritability of approximately 64%.
However, the genetic mechanisms of PWB are largely unknown despite its many important benefits. To
address this, we recently performed a genome-wide association study (GWAS) of positive emotion, a major
facet of PWB. We found a single nucleotide polymorphism (SNP), rs322931, significantly associated with
positive emotion at genome-wide level. This association has since been replicated in two independent
datasets. We subsequently found that rs322931 is a cis-expression quantitative trait locus (eQTL) for
microRNAs 181a and 181b (miR-181a/b) expressed in human blood and brain. Intriguingly, miR-181a/b are
enriched in the reward-motivation neural circuit and regulate synaptic plasticity and immune functioning in
animal studies. Taken together, we hypothesize that miR-181a/b play a role in PWB.
Given these exciting data, we propose to validate and extend our findings, leveraging already collected
human post-mortem brain transcriptomic, epigenomic, proteomic, and genomic data to elucidate molecular
mechanisms of PWB. This unique human brain dataset of 675 individuals, gathered by the NIH-funded Rush
Memory and Aging Project (MAP) over 20 years, provides a rare opportunity to investigate mechanisms of
PWB in the relevant organ, i.e. human brain, with 90% power for our proposed analyses.
To that end, we propose the following aims. Aim 1 will validate the genetic findings from our GWAS of
positive emotion in 2040 Veterans and MAP participants. Aim 2 will extend our findings by investigating the
contribution of brain microRNAs in PWB using both a hypothesis-driven and hypothesis-neutral approach.
Notably, microRNAs are important post-transcriptional regulators of gene expression and collectively
regulate more than half of the protein-coding genes. Aim 3 will employ innovative systems biology
approaches to identify gene networks and key expression regulatory drivers of PWB, as well as determine
whether their protein levels are correspondingly altered in PWB.
In sum, this novel and innovative proposal capitalizes on previously collected Veteran genetic samples
and human post-mortem brain “omic” data from the unique NIH-funded MAP cohort recruited over the last
20 years. We plan to combine these data with the ones we will generate and analyze them with innovative
systems biology approaches to elucidate molecular mechanisms of PWB. We aspire to elucidate the genetic
architecture of PWB to contribute to future efforts in developing biomarker based screening for risk
stratification and intervention to enhance PWB and its beneficial effects.

Public health relevance
This novel and innovative proposal aims to leverage already collected human post-mortem brain data to elucidate molecular mechanisms of psychological well-being (PWB). Insights into genes, gene networks, and proteins modulating PWB may provide a foundation for further mechanistic studies to develop biomarker- based screening for genetic predisposition to low PWB and novel intervention to enhance PWB. PWB confers protective effects against several of the mental and physical illnesses that are most relevant to Veterans, including suicide, substance abuse, depression, PTSD, dementia, heart disease, and diabetes. These illnesses are high priorities to the VA because they disproportionally affect Veterans. Insights into PWB may facilitate efforts in alleviating many illnesses that affect Veterans. Thus, this proposal is expected to have high scientific and public health impact.